Enhanced radiotherapy for pediatric glioma via synthetic lethal vulnerabilities

Project Summary
Diffuse midline gliomas (DMG) are the most common malignant brain tumors of children. They are surgically
inaccessible and refractive to chemotherapy. The prevalent oncogenic driver--an H3K27M mutation of histone
H3--is undruggable. Radiotherapy is the standard of care for DMG, and the only treatment that prolongs patient
survival. However, H3K27M DMGs inevitably recur following radiotherapy and are uniformly fatal. Against this
backdrop, we propose this R01 response to PAR-22-198 from the NCI entitled “Precision Approaches in
Radiation Synthetic combinations (PAIRS).” Our broad goal is to improve survival of children with DMG.
The point of departure for our study plan is a recently completed genome-wide CRISPR screen aimed at
identifying DMG-specific vulnerabilities. Our screen identified a conditional synthetic lethality at the junction of
replication stress (RS) and the consequent DNA damage response (DDR). This vulnerability is druggable and
has potential to enhance the efficacy of radiotherapy in DMG synergistically--a strategy specifically proposed
by PAIRS. Our testable hypothesis is that a sustainable balance between RS and DDR in DMGs can be
tipped to therapeutic advantage by combining radiation and ATR antagonists (which increase RS) or by
radiation plus inhibitors of DNA polymerase Q (which decrease DDR).
In collaboration with a corporate partner, we have identified clinical-stage, brain-penetrant antagonists of
ATR and POLQ. For clinical trials we are an integral member of the international Pacific Pediatric Neuro-
Oncology Consortium (PNOC). Drawing upon these resources, our aims are to test three specific predictions of
our hypothesis. Aim 1 (target specificity) tests the prediction that synergistic killing of DMG cells by the
combination of radiation plus ATR or POLQ antagonist reflects “on target” responses to enhanced RS or
suppressed DDR (induced by ATR or POLQ antagonist, respectively). Aim 2 (chromatin structure) tests the
prediction that the H3K27M driven altered chromatin propels dependency on ATR and POLQ. Aim 3
(therapeutic potential) tests the predictions that (a) the variability in DMG patient responses to radiotherapy
reflects patient-specific differences in the pre-therapeutic burden of DDR and RS and (b) that markers of RS
and DDR will correlate with response to therapy in “avatar clinical trials” with patient-derived xenografts of
DMGs.
The study plan is enabled by an interactive collaboration among three investigators whose skill sets exceed
the sum of their parts. Daphne Haas-Kogan, M.D. is a clinician-scientist with much practical experience in the
clinical care of children with DMG. As Chair of Radiation Oncology at Dana-Farber Cancer Institute, DHK
interacts frequently with Dipanjan Chowdhury, Ph.D. - a DNA enzymologist with deep expertise in DNA
replication and repair. In clinical studies proposed for Aim 3, DHK and DC will work closely with Sabine
Mueller, M.D. - an expert on the design and conduct of clinical trials and leader of the PNOC consortium.

Public health relevance
Project Narrative Diffuse midline gliomas (DMG) are the most common malignant brain tumors of children. Radiotherapy is the only treatment known to prolong patient survival but DMGs inevitably recur following radiotherapy and are uniformly fatal. The goal of the work proposed here is to build on our identification of conditional synthetic lethal vulnerabilities in DMGs to test a pair of drugs that have potential to greatly enhance the clinical benefit of radiotherapy for children with DMG.